CONTRIBUTION OF EVENING MEAL TO FASTING HYPERGLYCEMIC IN NIDDM

The purpose of this study is to determine the effect of the supper meal on fasting blood glucose levels and insulin secretion in non-insulin dependent diabetics. These parameters will be evaluated after 1) a day without supper, 2) a normal supper (14 Kcal/Kg of desirable body weight), and 3) a big supper (28 Kcal/Kg of desirable body weight).